Mechanisms of transcription factor integration at the c-myc promoter

We have been studying regulatory elements that are single-stranded when the human c-myc proto-oncogene is expressed and have been characterizing the conformation and topology sensitive DNA binding proteins that interact with these elements. First, a cell type, differentiation specific positive cis-element, FUSE, 1.5 kb upstream of promoter P1 is single stranded when c-myc is expressed in vivo and is devoid of nucleosomes except when c-myc is repressed. This element specifically binds FUBP, a sequence specific, single strand DNA binding protein. FUBP's amino terminus is a potent transcriptional repressor which interacts with TFIIH while the carboxyl is a powerful transcription activator. The activation domain of FUBP binds directly with the p62 subunit and the p89 helicase subunit of TFIIH. A co-repressor with FUBP, FIR, binds the central domain of FBP and interacts with TFIIH. FIR increases the affinity of FBP for binding with the FUSE element. FBP activation is defective in xeroderma pigmentosum cells mutated in TFIIH subunits. So endogenous c-myc expression is unresponsive to FUBP in XP cells. In XPB cells we have discovered that tight regulation of c-myc is lost and remarkable cell-to-cell variation in MYC levels occur. The XPB mutation prevents FUSE from looping and interacting with the major P2 promoter, as a result both the induction and shutoff of c-myc in response to serum addition and removal are impaired. Thus, the same mutation that disables nucleotide excision repair also deregulates a dangerous oncogene. Moreover we have discovered that this mutation also disturbs normal cell cycle progression and leads to an accummulation of cells in G2/M. Knockdown of FIR with siRNA provokes a similar cell cycle alteration and similarly disturbs the serum response of the c-myc gene. Along with FBP, two other family members FUBP2 and FUBP3 probably form a basis set to adjust the steady levels of important genes. The central domain of FBP mediates interaction with FUSE. This portion of the protein is composed of repeated "KH" motifs which comprise a bi-partite DNA binding domain. Sub-domains constituted of the amino-terminal two KH repeats or the carboxyl pair of KH motifs bind weakly and strongly, respectively with upstream and downstream contiguous sequence segments of FUSE. SELEX studies have identified specific DNA sequences interacting with FBP's KH domains and have enabled a genomic analysis of prospective FBP binding sites. Upon binding with FIR, the weak binding sub-domain of FUBP recognizes the upstream segment of FUSE with increased affinity. Both FBP and FIR have been shown to control levels of endogenous c-myc expression. FIR repression of c-myc also fails in XP cells. ChIP (chromatin immunoprecipitation)-Seq studies are revealing that the FBP-FIR system is a commonly used molecular machine that controls the output of a large number of genes. NMR studies of a complex between the strong binding sub-domain and the downstream segment of FUSE suggest that FUBP is truly a DNA binding protein as particular features of the complex are unique to DNA-protein interactions. X-ray crystallography in collaboration with Dr. Demetrios Braddock revealed new features of the FUBP-FIR-FUSE system. Recent evidence in collaboration with Leonie Quinn (Melbourne) shows that FUBP is likely to also interact with the Mediator complex. All of these interactions occur both in vivo and in vitro. The mechanism of transcriptional modulation by the FBP/FIR/TFIIH/repressor/co-activator complex reveals that FUBP hastens RNA polymerase movement through earliest stages of transcript elongation. In contrast FIR delays the transition of RNA polymerase into its elongation mode. mechanisms. The relevance of FUBP and FIR to the regulation of c-myc has been established using RNAi. Additional experiments have exposed the presence of multiple signals embedded within FBP targeting the protein to multiple nuclear compartments. We have developed an FUBP knockout mouse that dies just before birth and seems to display hematopoietic abnormalities. MEF and 3T3 cells from FUBP ko embryos have been developed to study the molecular mechanisms, targets, and cell dynamics that are under the control of FUBP. We have also developed a a c-myc-EGFP knock-in that is the best reporter system yet developed to study the regulation and deregulation of c-myc expression. combined with our studies of FIR and FUBP via DNA topology these studies provide an extra dimension to our understanding of gene regulation. We are using this system to provide new insights for the identification and understanding of MYC targets during lymphocyte activation. Recent studies in the lab have established that FUBP2/KHSRP, another FBP family cooperates with FBP/FUBP1 to control MYC levels. The properties of FUBP and hnRNP K that each bind to both single stranded DNA and RNA prompted examination of c-myc regulatory cis-elements in vivo and in vitro to determine how these sites become melted. Using actively transcribing T7 RNA polymerase to generate torque, experiments indicate that the dynamic transmission of mechanical stress destabilizes particular elements, such as FUSE and CT-elements, even in the absence of defined topological boundaries. Recent experiments have been devised to measure the level of superhelical stress transmitted into DNA by ongoing transcription. The level attained is close to the theoretical limit and is suprisingly high, high enough to disturb chromatin and DNA structures and so may of regulatory consequence. Recent studies are establishing the the equivalence of our in vitro and in vivo studies. Because single-stranded DNA is much more flexible to torsion and flexion than is duplex, interposing CT-elements between genetically interacting sites facilitates these interactions. Therefore one function of regulated single-stranded cis-elements is to serve as protein-DNA hinge. Recent work suggests that competition between hnRNP K and SP1 at the CT element may be mediated by a conformation switch. To explore the interplay between these DNA conformation sensitive factors and the multitude of conventional transcription factors that regulate c-myc, we have knocked EGFP as a chimeric protein into the c-myc locus. This knock-in allele is fully functional as homozygous myc-EGFP mice are phenotypically normal. The EGFP allows us to monitor MYC levels in single, living cells. This will allow us to describe the distribution of cell-to-cell variation in MYC levels with the quantitative precision necessary to develop a predictive mechanistic model if how the c-myc promoter works. Why is c-myc regulation so complicated? We have determined that even a brief pulse of forced MYC expression can cause cells to undergo several cycles of cell division. Therefore expression must be held to close tolerances. Using a new nuclease assay developed by us we are commencing the the analysis of the differential utilization of cis-reguatory modules that control MYC expression in helath and disease. We demonstrated that MYC levels have precise and epigentically fixed set points in different cells and that these set points are disturbed in cancer. With low level stimulation, cells induce MYC while respecting a ceiling that is epigenetically bounded, but with high level stimulation this ceiling may be breeched and pathological MYC levels ensue. The high-MYC cells are primed for a rapid response to stimulii. Strategies are beginning developed to use Nanopore long-read sequencing of DNA recovered from cells treated with DNA-confomration sensitive agents in order to study the usage, coordination, and cooperation of cis-elements distributed throughout the MYC locus that sensitive to DNA topology and dynamic supercoiling. This approach promises to reveal DNA mechanics operating to provide realtime regulation of ongoing transcription.